S.E.N.D.: Developing a web-based, interactive guide to enhance patient-clinician electronic communication by focusing on specificity, expressing concerns, need, and directness

Project Summary
The use of secure messaging (SM) is increasingly being relied upon for cancer communication. SM can improve
care and provide an outlet for patient-clinician communication. However, patients are uncertain about how to use
SM effectively to communicate with clinicians, and clinicians have cited difficulties understanding the goals of
patients’ messages. The long-term goal is to perform a wide-scale implementation to integrate the evidence-
based, online, interactive tool with the electronic health record (EHR) system to facilitate quality health care
communication between patients and clinicians. The objective of this proposal is to test the feasibility and
acceptability of the application to enhance patients’ message writing skills by conducting interviews with cancer
patients, followed by surveying patients after they have used the application, and finally, rating messages
pre/post-application for clarity, directness, organization, and structure. The rationale of this proposal is that just
like in face-to-face communication training, developing materials that focus on specific communication
challenges can enhance how patients communicate with clinicians, leading to higher efficiency, satisfaction,
knowledge, and self-efficacious behavior. Ensured by the strong track record of the team comprising Alpert (PI),
an expert in cancer patients’ health communication using technology, Bylund’s (Co-I) extensive experience
developing communication skills training programs, Markham’s (Co-I) specialty in cancer care, Wang’s (Co-I)
methods and analysis expertise, Murphy’s (Co-I) experience interacting with patients using SM, and supported
by the UF Health Cancer Center, our three aims are realistic to be completed within the specified timeframe and
hold the potential to greatly enhance the quality of communication. Our study is innovative because we will
provide a theoretically grounded, interactive intervention to help patients learn specific communication skills
related to SM, and evaluate its effectiveness by including clinicians as message raters. Our study would also
provide valuable insights into how clinicians perceive quality SM communication, enabling future interventions
focusing on clinicians’ techniques to responding to messages. The proposed research is significant because
although SM is widely used, no guidance about how to use it effectively is currently provided. The anticipated
positive impact of this project is that it will provide evidence to confirm that education for SM is necessary and
effective. A multi-level intervention will be planned to integrate the application into the EHR to be suited for a
wide variety of disease areas.

Public health relevance
Project Narrative This project aims to improve cancer patients’ online communication using secure messaging by developing and evaluating a web-based application designed to help patients craft effective messages. Since patients do not receive any guidance or instruction about how to write electronic messages to clinicians, we will utilize mixed methods, such as interviews and surveys, to provide patients with techniques focusing on specificity, expressing concerns, stating needs, and directness. Patients will complete an online survey about their experience using the application and clinicians will rate messages pre- and post-application.